Evaluating the implementation and impact of navigator-delivered ePRO home symptom monitoring and management

PROJECT SUMMARY
Randomized controlled trials by Basch (collaborator) and colleagues demonstrated that weekly electronic
home-based PRO symptom monitoring with automated alerts to clinicians (Home ePRO) in cancer patients
was associated with reduced healthcare utilization, improved quality of life, and increased overall survival.
However, these trials were administered using infrastructure supported by research funding. A knowledge gap
remains about optimal implementation strategies for and effectiveness of Home ePROs in real-world settings.
To address this gap, investigators from two institutions will conduct a large-scale, population-based
implementation of an evidence-based Home ePRO intervention for all adult cancer patients receiving
chemotherapy, including vulnerable populations such as African Americans, rural residents, and
socioeconomically disadvantaged individuals. This implementation will leverage infrastructure from Medicare's
payment reform projects (Oncology Care Model, Oncology Care First Model), which require and financially
support patient navigators, a natural workforce for Home ePRO implementation. Our hypothesis is that the
deployed implementation strategies will result in successful navigator-delivered Home ePRO, which will
improve both patient and health system outcomes. Using the Consolidated Framework for Implementation
Research (CFIR), this hypothesis will be tested using a hybrid type 2 design with three specific aims: 1)
evaluate implementation of navigator-delivered Home ePRO for all cancer patients across multiple practice
sites; 2) examine the barriers, facilitators, and implementation strategies used in implementing navigator-
delivered Home ePRO; and 3) assess the impact of Home ePRO on clinical and utilization outcomes. In Aim 1,
Home ePRO will be evaluated using implementation outcomes (service penetrance, provider
adoption/penetration, intervention fidelity). In Aim 2, we will gauge patient and healthcare team perceptions of
barriers and facilitators of navigator-led Home ePRO, implementation strategies used to address these
barriers, implementation strategy fidelity, and perception of implementation strategy ability to address barriers
using an iterative qualitative analysis. In Aim 3, patient-level outcomes (functional status, distress, depression,
healthcare utilization, cost, survival) will be evaluated using real-world data sources. The project is innovative
because it will be the first study to evaluate real-world implementation of navigator-led Home ePRO for all
cancer patients receiving chemotherapy, an approach that is both immediately scalable and sustainable within
value-based payment models. The proposed research is significant because it is expected to demonstrate
successful implementation of navigator-delivered Home ePRO and effectiveness of the ePRO intervention on
diverse patient populations. Furthermore, the project will generate an implementation blueprint of successful
implementation strategies that can be easily applied to other patient-reported outcomes, with the potential to
positively impact patient care as health care transitions to a value-based system.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will evaluate implementation strategies for and effectiveness of navigator-delivered electronic patient-reported outcome home symptom monitoring and management (Home ePRO). Once the success of these strategies is demonstrated, there is potential for broad implementation of navigator-delivered Home ePRO to ultimately reduce patient symptom burden, minimize adverse outcomes associated with uncontrolled symptoms, and significantly advance the field's knowledge of optimal approaches to patient-reported outcome implementation. Thus, the proposed research is relevant to the NIH's mission with respect to reducing illness and disability.